Extracellular vesicles from endothelial colony forming cells as paracrine mediators of neurovasculotrophic repair of the retina

Project Summary/Abstract:
Current treatments for ischemic retinopathies are designed to inhibit vascular leakage and proliferation in late
disease, but do not target the ischemia and/or inflammation driving pathological neovascularization. A
promising alternative approach is the stimulation of functional, physiologic vascular growth and stability. A
subset of endothelial progenitor cells called endothelial colony forming cells (ECFCs) can facilitate this. In
mouse models of ischemic retinopathy (oxygen-induced retinopathy, OIR), ECFCs provide a significant
vasculo- and neurotrophic rescue effect. Several lines of evidence, including published findings from our lab,
demonstrate this therapeutic effect to be mediated via paracrine action. However, the details of this
mechanism remain uncharacterized.
MicroRNA-containing extracellular vesicles (EVs) shed from ECFCs were recently discovered to recapitulate
this rescue effect in the OIR model. ECFC-derived EVs promote endothelial cell migration and increase the
expression of angiogenesis-related genes. The Friedlander lab has demonstrated that a subset of ECFCs
characterized by high expression of the surface marker CD44 (CD44hi) exhibit a more robust vasculo- and
neurotrophic rescue effect than ECFCs with low CD44 expression in the OIR model via a paracrine
mechanism. In light of these data, the overarching hypothesis of this proposal is that the superior effect of
CD44hi ECFCs is attributable, at least in part, to the bioactive microRNA (miR) cargo in EVs released from this
ECFC subpopulation. I propose to investigate which miRs are upregulated in EVs shed from CD44hi ECFCs in
order to identify novel miRs responsible for the reported neurovasculotrophic effects of ECFC EVs. EVs will
then be engineered to increase expression of these candidate miRs with the goal of re-designing therapies that
achieve even greater therapeutic effects in the OIR model.
As natural carriers of miRs, EVs may be a highly effective drug delivery vehicle that circumvents the risks of
tumorigenesis associated with cell-based therapeutics. ECFC-derived EVs home to sites of
ischemia/angiogenesis, potentially limiting any deleterious side effects of systemic delivery. However, a greater
understanding of heterogeneous populations of EV and the relationship between their cargo and functional
effects must be developed before translation into the clinic can become a reality.

Public health relevance
Narrative: Endothelial colony forming cells (ECFCs), a subset of endothelial progenitor cells, provide a promising alternative approach to the treatment of ischemic retinopathy due to their promotion of physiologic vascular growth and stability via a paracrine action. Recent studies have shown that microRNA-containing extracellular vesicles (EVs) shed from ECFCs reduced the area of vaso-obliteration and upregulated genes associated with angiogenesis in the oxygen-induced retinopathy model of ischemic retinopathy. In this application, I propose to investigate an EV-mediated paracrine mechanism underlying our lab's recently published discovery that a subset of ECFCs (characterized by high expression of the surface marker CD44) exhibit a superior neuro- and vasculotrophic paracrine rescue effect in rodent models of ischemic retinopathy and retinal degeneration.